2023 Phagocytes Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY/ABSTRACT
The Phagocyte Gordon Conference (GRC) and associated Gordon Research Seminar (GRS) will be held June
3-9, 2023 at Waterville Valley, NH. This will be the 22nd iteration of this GRC. Phagocytes are cells that have the
capacity to engulf other cells or particles. Phagocytes include cells of the immune system such as neutrophils,
monocytes/macrophages, and dendritic cells, analogous cell types in flies and worms, “nonclassical” phagocytes
like microglia, and single-celled amoeba. While phagocytes are central to immunity, they also play roles in tissue
homeostasis and development. When dysregulated, phagocytes contribute to prominent pathologies including
atherosclerosis, diabetes, cancer, autoimmunity, and infectious diseases. The theme of the 2023 Phagocytes
GRC is “Molecular and Cellular Diversity in Host Defense and Inflammation.” It will be the premier forum for
sharing the most recent unpublished discoveries in phagocyte biology. Featured topics include phagocyte
differentiation and plasticity, mechanisms of migration and phagocytosis, autophagy and cell death mechanisms,
microglia and neuroinflammation, phagocytes in cancer, host-pathogen interactions, phagocyte crosstalk,
interaction with the microbiota, and technological innovations in phagocyte biology. Novel translational
approaches for phagocytes in different diseases will also be covered. Attendees are leading international
scientists in cell biology, molecular genetics, microbiology, immunology, bioengineering, and clinical medicine.
The average attendance is 148 attendees. In 2022 (postponed from 2021 due to COVID-19), 52.3% of attendees
were women and 55.4% were graduate students or postdocs. The 2023 Phagocytes GRC features 13 female
and 11 male invited speakers (54.2% female), with one keynote speaker, who will present their exciting
unpublished findings. 37.5% of speakers identify as URM. Nine sessions will be chaired by discussion leaders
who are experts in the field. As in past GRCs, 16 early-career scientists (graduate students, postdocs, assistant
professors) will be selected for short talks based on submitted abstracts, and another 16 will give a brief preview
of their poster. Approximately 120 posters will be presented in sessions that do not overlap with the talks. To
enhance the participation and professional development of students and postdocs, a GRS will take place
immediately prior to the start of the GRC (June 3-4). Organized and chaired by trainees, the GRS is an inclusive
environment for the next generation of phagocyte scientists to share their research and build community. A
comprehensive Diversity Plan will ensure that attendees and presenters are from diverse backgrounds and the
conference environment is inclusive and equitable. The 2023 Phagocytes GRC and GRS will serve as a nexus
for sharing cutting-edge unpublished research in phagocyte biology, thereby facilitating communication and
collaboration between investigators studying different aspects of phagocytes, providing an inclusive and
supportive environment for trainees and young investigators to network, and ultimately identifying translational
and therapeutic targets of phagocytes in human health.

Public health relevance
PROJECT NARRATIVE Phagocytes are cells that are essential for immunity and development, but if they are dysregulated, they contribute to prominent diseases including autoimmunity, infections, cardiovascular disease, diabetes, and neurological conditions like Alzheimer's disease. The 2023 Gordon Research Conference on Phagocytes and its associated Gordon Research Seminar will bring together a diverse group of leading scientists from around the world, as well as early-career investigators who are the future of the field, in a residential location that fosters conversation and community-building. The Gordon Research Conference on Phagocytes offers an unparalleled collegial environment for sharing and discussing unpublished, cutting-edge research that can lead to new ways to identify and treat a broad range of diseases that are important to human health.